Project 2: Next Generation TOP1 Inhibition for the Treatment of Ovarian Cancer

ABSTRACT – PROJECT 2
Inhibitors of the DNA repair enzyme poly(ADP-ribose) polymerase 1 (PARP1) are highly active in homol-
ogous recombination (HR)-deficient ovarian cancers, especially those with BRCA1 or BRCA2 (BRCA1/2) muta-
tions. Even in this setting, however, 40-80% of cases become PARP inhibitor (PARPi) resistant, most often as
a result of genetic or biochemical changes that restore HR. Among other genomic subsets of ovarian cancer,
PARPi resistance is even more prevalent. The observation that most common mechanisms of acquired PARPi
resistance do not result from a failure to inhibit PARP1 raises the possibility that PARPis can potentially be
utilized as chemosensitizing agents in this setting if suitable combinations can be identified. Accordingly, the
present project seeks to enhance the efficacy of the PARPi rucaparib and extend its use by combining it with a
3rd generation topoisomerase I (TOP1) inhibitor (TOP1i). Recent studies have shown that nanoparticle
formulations such as PLX038, a polyethylene glycol-conjugated ultra-long acting form of the TOP1i 7-ethyl-10-
hydroxycamptothecin (SN-38), exhibit less marrow toxicity and greater efficacy than conventional TOP1is in
preclinical cancer models. Our preliminary studies show that sustained release TOP1is, including PLX038, are
active against five of seven PARPi-resistant ovarian cancer patient-derived xenografts (PDXs) tested. Moreover,
using a unique antibody that detects TOP1-DNA covalent complexes (TOP1ccs), which are intermediates in the
TOP1i-induced killing process, we have shown that TOP1ccs are diminished or undetectable in PDXs that are
resistant to the TOP1i/PARPi combination, providing a starting point for understanding ovarian cancer resistance
to this treatment. Collectively, these results lead to the hypothesis that a readily identifiable subset of HR-
proficient ovarian cancers will exhibit sustained antitumor effects when treated with a next generation
TOP1i alone or in combination with a PARPi. To test this hypothesis, we now propose to i) assess the efficacy
of PLX038, alone and in combination with the PARPi rucaparib, in a cohort of genomically profiled high grade
serous ovarian cancer PDXs with intrinsic or acquired resistance to single agent PARPis to identify the spectrum
of ovarian cancers that could potentially benefit from PLX038 or the combination; ii) identify mechanisms of
resistance to the TOP1i/PARPi combination in PDXs and cell lines; and iii) examine the association between the
formation of drug-stabilized TOP1-DNA covalent complexes in tumor cells and the response of ovarian cancer
patients to the PLX038/rucaparib combination in a phase II clinical trial. Collectively, these studies will not only
provide insight into the genomic and biochemical factors that affect response to a 3rd generation TOP1i in ovarian
cancer, but also determine whether it is possible to use PARPis as chemosensitizing agents in settings where
they are no longer active as single agents. If successful, this project will point to a new therapy for the growing
number of women with PARPi-resistant ovarian cancer.

Public health relevance
NARRATIVE – PROJECT 2 Treatment options are limited for women whose ovarian cancer has become resistant to platinum drugs and PARP inhibitors. Clinical studies have shown that prolonged schedules of DNA topoisomerase I (TOP1) inhibitors can be effective in some platinum-resistant ovarian cancers. Our preclinical studies have also shown that PARP inhibitors can enhance the antitumor effects of TOP1 inhibitors in vitro and in ovarian cancer patient derived xenograft (PDX) models despite resistance to the antitumor effects of PARP inhibitor alone. These observations, which reflect the fact that PARP inhibition and PARP inhibitor-induced tumor cell killing are related but separable processes, provide the opportunity to use PARP inhibitors as chemosensitizing agents in ovarian cancers that are PARP inhibitor resistant. Accordingly, this project will study the action of a promising 3rd generation ultra- long acting TOP1 inhibitor, PLX038, in combination with the PARP inhibitor rucaparib in preclinical models and in a phase II clinical trial in platinum- and PARP inhibitor-resistant high grade serous ovarian cancer.